Integration of circadian and homeostatic signals in a peptidergic circuit in Drosophila

Project Summary/ Abstract
There is rapidly accumulating evidence that disruptions of circadian patterns of sleep, activity and feeding lead
to deleterious health consequences. While circadian clock mechanisms are well-studied, the relationship
between time-of-day cues and homeostatic drives such as hunger are poorly understood. The integration of
circadian information with nutritional cues occurs downstream of the core clock cells in the brain at the
intersection of multiple behavioral circuits. This proposal exploits the Drosophila melanogaster genetic
model to examine the mechanism by which circadian signals integrate with feeding circuitry to
coordinate locomotor rhythms with feeding behavior. The Drosophila pars intercerebralis (PI), an analog of
the mammalian hypothalamus, is a peptidergic center that receives both time-of-day and nutritional state
information. Based on published and preliminary findings, it is likely that that the PI receives excitatory input from
core clock neurons via neuropeptide signals, as well as inhibitory inputs from cholinergic Hugin-producing
gustatory interneurons. The central hypothesis of this proposal is that each of the peptidergic PI populations
(DH44+, insulin-like peptide producing, SIFamide+ and Taotie) receives a unique set of inputs, which must then
be integrated within the PI to coordinate behavioral outputs, and that this integration occurs via intra-PI paracrine
neuropeptide signaling. Thus, PI populations likely modulate both rest:activity rhythms and feeding behavior
depending on nutritional state to allow responses to acute environmental cues. In the mentored phase of this
project the applicant will characterize the connectivity from the central brain clock (Aim 1) and the hugin+
gustatory interneurons (Aim 2) to the PI and examine how each of these circuits modulates feeding and
rest:activity behavior (Aims 1 and 2). In the independent phase of this project the applicant will use skills gained
in the mentored phase to investigate how starvation overrides clock control of PI neuron physiology and behavior
(Aim 3) and the role of intra-PI connectivity in coordinating locomotor rhythms and feeding behavior (Aim 4). To
pursue these aims the applicant will use a combination of genetic tools including RNAi and CRISPR,
physiological assays including electrophysiology and calcium imaging, and behavioral assays for locomotor
rhythms and feeding. Successful completion of this project will offer important advances at both the level of
neural circuitry and behavior. First, it will begin to elucidate how intersecting circuits communicate using
neuromodulatory peptides. Neuromodulatory signaling has proven difficult to study in mammalian systems, and
this work can offer insights that will be applicable to studies of neuropeptidergic regions in mammals, particularly
in the hypothalamus. Second, it will advance understanding of the complex interplay of circadian rhythms and
feeding both at the circuit and behavioral levels. Understanding not only how circuitry shapes behavior, but how
behavior such as altered feeding patterns feeds back to the brain is important for developing interventions to
improve human health.

Public health relevance
Project Narrative To maximize homeostasis and survival organisms must coordinate circadian information with information about acute environmental changes and disruption of this coordination contributes to chronic health issues. How the brain integrates information coming from internal homeostatic drives and external environmental cues to coordinate behavior is still not understood. The goal of this project is to determine how a specific brain region acts as a hub to integrate information from multiple sources to coordinate feeding and locomotor behavior.